A Phase 1 Adaptive Dose Escalation Study of Mycophenolate Mofetil in Combination with Temozolomide for Patients with Newly Diagnosed Glioblastoma

PROJECT 4: PROJECT SUMMARY
Glioblastoma (GBM), a grade IV tumor, is one of the most aggressive and infiltrative brain cancer forms. Patients
currently diagnosed with Glioblastoma (GBM) have an abysmal prognosis. The median survival is around 8-10
months, even after the standard care protocol of surgical resection followed by alkylating chemotherapy (typically
temozolomide or TMZ) and radiotherapy. This is because, in nearly all patients, the tumor recurs after treatment
since GBM cells can become resistant to therapy. Our laboratory's goal is to develop a treatment for GBM that
will reduce the recurrence rate and improve the prognosis for patients. One of the distinguishing characteristics
of cancer is its uncontrolled cell division. Since cancer cells divide more rapidly than normal cells, they require
more purines, the building blocks of DNA and RNA. Purines are either synthesized from amino acids and other
small molecules through the de novo biosynthesis pathway or are recycled from the microenvironment through
the salvage pathway. Cancer cells use the de novo biosynthesis pathway, whereas the central nervous system
usually relies more on the salvage pathway. We have identified ARL13B as a novel regulator of the purine
biosynthesis pathway during chemotherapy through initial analysis. ARL13B, a member of the ADP-ribosylation
factor-like family protein accountable for cilia maintenance, directly interacts with inosine monophosphate
dehydrogenase 2 (IMPDH2), the rate-limiting enzyme purine biosynthesis. Our initial studies knocking down
ARL13B inhibited GBM cells' utilization of the de novo pathway after TMZ treatment and increased utilization of
the salvage biosynthesis pathway. The effectiveness of TMZ treatment was also elevated in vitro and in vivo
following ARL13B knockdown. We, therefore, proposed that the ARL13B-IMPDH2 regulated switch from the
salvage pathway to the de novo purine biosynthesis pathway is necessary for GBM cells' adaptation to alkylating-
based chemotherapy. Based on this, we hypothesize that therapeutic transformation in GBM involves interaction
between ciliary protein ARL13B and rate-limiting purine biosynthesis enzyme IMPDH2 Mycophenolate mofetil
(MMF), an FDA-approved drug in the organ-transplant setting, inhibits IMPDH2 activity and allows for increased
the therapeutic efficacy of TMZ and extended the survival of patient-derived xenograft (PDX) models across
multiple GBM subtypes. This provides a clinically translatable opportunity to overcome chemoresistance in GBM.
In this proposal, we set to conduct a Phase 1/1b clinical trial of MMF combined with standard chemo- and
radiotherapy for newly diagnosed GBM. The primary objectives are to evaluate this novel combination's safety
and toxicity and establish the maximally tolerated dose (MTD). Exploratory secondary endpoints include
progression-free and overall survival. Furthermore, we intend to investigate mycophenolic acid, an immediate
metabolite of MMF that can serve as a biomarker for such therapy.

Public health relevance
PROJECT 4: PROJECT NARRATIVE Glioblastoma (GBM) is the most common and lethal brain tumor due to its aggressiveness and ability to resist conventional radio- and chemotherapy. Elucidating the mechanism of chemoresistance is vital to developing an effective therapeutic intervention. This project proposes conducting a Phase 1 clinical trial of mycophenolate mofetil (MMF), an FDA-approved drug from the organ-transplant setting, in combination with standard chemo and radiotherapy for newly diagnosed patients with GBM.